Defining and Optimizing Critical Interpretation Skills in Screening Mammography to Improve Cancer Detection

Project Summary Abstract
There is a critical lack of information regarding how radiology residents develop interpretive skills for
screening mammography. Consequently, little is known how to avert or correct errors in perception and
cognition. The majority of radiology residents have only the required minimum 12 weeks of breast imaging
training. Yet, the majority of mammograms in the United States are interpreted by general radiologists, not
board-certified breast imagers. The negative impact on patient care by not filling this gap in education is
continued missed cancers and unnecessary additional imaging and biopsies. The long-term goal of this project
is to reduce interpretive errors in breast imaging for improved patient outcomes by providing objective tools
and resources to improve trainee education.
The overall objectives of this proposal are to understand cognitive and perceptual skill development in a
specialized simulation system by bringing together experts in radiology, computer science, educational
psychology, and psychology. In residency there is no opportunity for residents to interpret mammographic
studies independently from attending radiologists. Thus, offering no opportunity to ‘practice’ their skills. Our
education system needs improvement. This project will implement a specialized simulation system with
sequential evaluation of radiology resident performance in screening mammography providing objective
measures and feedback to trainees. The central hypothesis of this project is that a systemized simulation
screening mammography system within residency training will aid in identifying critical cognitive and perceptual
errors that negatively impact patient care and outcomes. This hypothesis will be tested by three specific aims:
1) Use machine learning tools to develop congruent case sets for consecutive simulation sessions. 2) Assess
the impact of sequential simulation training and examine predictors of individual differences in learning
trajectories, by a) assess interpretive skills of radiology residents and fellows in the breast screening simulation
system, b) assess real-time perception skills with eye tracking in simulation sessions, and c) assess the
resident’s fundamental cognitive and perceptual abilities as well as personality traits. 3) Assess and quantify
the effects of sequential simulation training.
This research proposal is innovative, in that it provides sequential opportunities for radiology residents
to independently interpret screening mammograms in a specialized simulation system that will obtain
information about the development of interpretive and perceptive skills over time during real-world practice.
This research proposal is significant because simulation training is effective at taking high-risk stakes skills and
putting them in a low risk encounters to assess and improve performance. Improving the preparation of
radiology residents to interpret screening mammograms will have far reaching impact on women’s health and
overall public health.

Public health relevance
Project Narrative This proposed research is relevant to woman’s health and overall public health by implementing a specialized breast screening simulation system within radiology residency to study the interpretation and perception skills that occur over time. These findings will aid in developing tools that can avert or correct interpretation errors early in resident education to reduce missed cancers and unnecessary additional imaging and biopsies. Thus, this proposal is relevant to the NIH’s mission to improve the accuracy of breast cancer detection through training and education.